Osteogenic Niche Biology in Progression and Endocrine Resistance of Bone Metastases

Project Summary:
Anti-­steroid therapy is standard of care therapy for both ER+ breast cancer and for prostate cancer. Both
cancers metastasize predominantly to bone. Estrogens and androgens are also key mediators of normal bone
growth, homeostasis, and maintenance of the osteogenic niche in both females and males. Both cancers
metastasize to the osteogenic/hematopoietic niche in trabecular bone. Accordingly, the early stage bone
colonization of prostate and ER+ breast cancer may involve similar osteogenic cell-­dependent mechanisms.
The osteoprogenitor and osteoblasts in the osteogenic niche are regulated primarily by ERα and AR actions in
both genders. Deficiencies these receptors often translate into severe pathological bone conditions. Thus, any
anti-­steroid therapies targeting prostate and ER+ breast cancers will also inevitably affect the
microenvironment, i.e., the osteogenic niche cells. However, there is a lack of understanding of how anti-­
steroid therapies affect the biology of osteogenic niche cells, and how this affects cancer progression and
evolution to therapeutic resistance. The Zhang and Rowley laboratories have both developed novel 3D
osteogenic heterotypical organoid models that addresses human breast and prostate cancer cells interaction
with human osteogenic cells respectively. Moreover, novel intra-­iliac artery injection and mouse calvaria
intravital imaging models have permitted the study of direct interactions with the osteogenic niche in trabecular
bone in vivo. Preliminary data suggests anti-­steroid therapy may result in a repair phenotype in the osteogenic
niche that may promote cancer progression and therapeutic resistance. Hence, it is our hypothesis that anti-­
steroid therapy affects the osteogenic niche to a more homeostasis-­repair phenotype that is cancer-­promoting.
To address this, we propose two Specific Aims. Specific Aim 1. To address bone osteogenic niche -­ cancer
interactions in differential steroid and anti-­steroid action conditions using novel 3D osteogenic organoid
approaches. This Aim will address the relative importance of ERα, ERβ, and AR in mediating estrogen,
androgen, and anti-­steroid actions in the genesis of a reactive osteogenic niche, how it affects breast and
prostate cancer biology, and how it alters anti-­steroid therapeutic efficacies. Specific Aim 2. To address
mechanisms of anti-­steroid (estrogen and androgen) biology in the osteogenic niche and how this affects
colony initiation and progression of breast and prostate cancer in vivo. Using genetically engineered mouse
models, novel tumor transplantation approaches and cutting-­edge intravital microscopy, we will examine the
impact of anti-­steroid treatments on the osteogenic niche in vivo and how it leads to endocrine resistance. The
overall goal of this multi-­PI proposal is to identify common mechanisms of osteogenic niche biology that affects
the evolution of breast and prostate metastatic progression during anti-­steroid therapy. These pathways may
represent targets for novel therapeutic approaches.

Public health relevance
Relevance: The efficacy of anti- steroid therapy for ER+ breast and prostate cancer can be improved by understanding the mechanisms of how these therapies affect the osteogenic niche microenvironment in bone. Mechanisms are not understood. Understanding mechanisms can lead to new therapeutic approaches to target the osteogenic niche tumor microenvironment to improve efficacy of therapy for metastatic breast and prostate cancer.